Myeloid cells as mediators of glaucomatous axon self-destruction

There are ongoing clinical trials premised on the idea that systemic treatments that increase
Nicotinamide Adenine Dinucleotide (NAD+) will increase baseline metabolism within retinal
ganglion cells (RGCs) which will make them more resilient to increases in intraocular pressure or
other insults that might result in the characteristic pattern of axon and vision loss that defines
glaucoma. However, much of our understanding about how NAD+ mediates neuroprotection
derives originally from studies of Wallerian Degeneration Slow (WldS) mice, which after traumatic
injuries have not only a ten-fold delay in axonal degeneration but also greatly delayed
inflammation. Very recently, using a novel optic nerve crush (ONC) model in young Xenopus
laevis (X. laevis) tadpoles, we reproduced the strong axon protective effect of the NAD+ boosting
interventions and similarly found a large inhibition of myeloid cell recruitment to both the optic
nerve and the main brain innervation target of RGCs. However, we then demonstrated that
pharmacogenetic ablation of myeloid cells fully recapitulates the axon preservation afforded by
the NAD+ boosting interventions. Our studies thus suggest that at least some of the
neuroprotection afforded by NAD+ boosting interventions may be due to their anti-inflammatory
activity. Here, we will determine whether NAD+ based interventions also work in a less traumatic,
more glaucoma relevant, novel axon injury model that is based on conditional expression in RGCs
of a rare glaucoma-associated Optineurin (OPTN) variant that produces extensive axonal loss.
We will characterize the immune reaction in this model and determine whether immune cells are
similarly consequential to the axonal degeneration. And then, using another novel axon
degeneration model based on conditional expression in RGCs of a constitutively active form of
the NAD+ catabolic enzyme Sterile Alpha and toll/interleukin-1 resistance (TIR) motif containing
1 (Sarm1), we will directly test the hypothesis that the timing of axon destruction due to NAD+
consumption within RGC axons in vivo is necessarily dependent on the consequent immune
invasion. We will also test a corollary hypothesis, namely that injured axons damage healthy
axons through the immune cells they recruit. In the process of answering these mechanistic
questions about how axons may be damaged in glaucoma, this proposal will develop and
characterize two novel axon injury models that we hope to use in the near future for large-scale
genetic and pharmacological screens.

Public health relevance
Recent experiments using Xenopus tadpoles suggest that various NAD+ boosting interventions may protect retinal ganglion cell axons after an optic nerve crush not only by what they may do within these cells but also because they inhibit the neuroinflammatory response to the injury. To determine the generality of this finding, retinal ganglion cell axons will be damaged by expression of a glaucoma-associated Optineurin variant or an engineered NAD+ degrading enzyme, and this will be done in the presence or absence of immune cells. Whether degenerating axons can affect healthy axons will also be determined, and if they do, whether this effect is mediated by immune cells as well.